Force Clamp Systems for Evaluation of Mechanotransduction

DESCRIPTION (provided by applicant): This work proposes a fully integrated approach to the study of mechano-electrical transduction in the sense of touch and focuses on the development of a novel microsystems-based tool-namely, a force clamp that uses appropriately-scaled piezeoresistive cantilevers as direct force sensors (PR force clamp). The proposal includes work to fully characterize the capabilities of a first-generation device, to design and build a second- generation device capable of operating at higher bandwidth, and to use these devices to analyze and model the biomechanics offeree transfer and mechano-electrical transduction by a model mechahoreceptor cell, the touch receptor neurons that innervate the body wall of the nematode Caenorhabditis elegans. C. elegans is an excellent biological platform for developing the proposed tools, which are likely to find application in the study of mechano-electrical transduction in other mechanosensory cells including vertebrate hair cells and dorsal root ganglion. A set of only six touch receptor neurons is responsible for behavioral responses to touch in C. elegans (compared to tens of thousands in vertebrates) and such responses are initiated by activation of the MEC-4 channel complex by forces applied to the body wall. Prototype force clamp systems use PR force clamps and piezoelectric actuators with programmable controllers to apply calibrated nano- to micro-Newton point load profiles with >1kHz bandwidth. A critical and innovative aspect of this work is the integration of the PR force clamp with patch-clamp electrophysiology for synchronous force-displacement- physiological recordings. This technology will enable the first direct measurement of dynamic changes in tissue stiffness that may occur during mechano-electrical transduction and give rise to adaptation. Relevance to public health. The sense of touch can be degraded by both inherited and acquired disease, including AIDS and diabetes, as well as by chemotherapeutic drugs. Complications from such peripheral sensory neuropathies are estimated to cost more than $4 billion annual in health care costs. Despite this, the sense of touch and its degradation in disease remain poorly understood. The research tools developed in the course of this work have the potential to significantly advance our understanding.